The Environmental Triggers of Diabetes (TEDDY) in Sweden

PROJECT SUMMARY/ABSTRACT
The Environmental Determinants of Diabetes in the Young (TEDDY) study was initiated in 2003 by six clinical
centers in the United States and Europe, including ours, to identify infectious agents, dietary factors, or other
environmental exposures that may trigger or protect against the development of islet autoimmunity and type 1
diabetes (T1D). Additional long-term scientific goals include assessment of potential gene-environment
interactions affecting development of islet autoimmunity or T1D, gaining insight on triggering mechanisms
through detailed multi-omics analyses, and sharing collected specimens with broader scientific community for
studies of T1D pathogenesis and prevention.
A total of 424,788 newborns were screened by HLA-DR,DQ genotyping to identify children at increased risk
for T1D and 8,676 enrolled for quarterly follow-up until age 4 and semi-annually thereafter until age 15. Now,
13 years after enrollment began, 5731 (66%) remain actively engaged in the protocol. Our TEDDY SWEDEN
Center enrolled 2525 TEDDY participants. As of 2/28/18, there are 139 SWE children with two or more islet
autoantibodies, 122 with one islet autoantibody and 87 who have been diagnosed with diabetes.
Detailed analyses of biological samples from the entire cohort, along with even more comprehensive multi-
omics analyses in selected individuals, will provide a rich dataset to complement the intensive collection of
exposure data and highly efficient ascertainment of islet autoimmunity and T1D endpoints in the entire cohort.
Specific aims of this renewal application for this multi-center, prospective cohort study for the next 5 years are:
1. Follow the TEDDY cohort of high-risk children for development of islet autoimmunity, diabetes,
celiac disease and autoimmune thyroid disease until 15 years of age; collect biological
specimens and epidemiological data according to the study protocol.
2. Characterize genetic, epigenetic, transcriptomic, proteomic and metabolomic determinants of
islet autoimmunity and T1D in the study participants.
3. Prospectively assess infectious, dietary and other environmental exposures of study
participants as triggers of islet autoimmunity, promotors of progression to T1D, or both.
A successful study outcome will provide a dataset unprecedented in depth and breadth, to help elucidate
specific exposures and mechanisms serving in the etiology and pathogenesis of islet autoimmunity, T1D, and
closely related autoimmune diseases. The results will support the development of new strategies to prevent,
delay, or reverse the disease.

Public health relevance
Project Narrative: The Environmental Determinants of Diabetes in the Young (TEDDY) Study is designed to intensively study high-risk children from infancy to 15 years of age, at six clinical centers across four countries (Finland, Sweden, Germany, and the USA in Georgia/Florida, Colorado, and Washington). The primary objective of this multi-center, prospective cohort study initiated in 2003 is the identification of infections agents, dietary factors, or other environmental exposures that trigger or protect against the development of islet autoimmunity and type 1 diabetes (T1D), including information on pathophysiological mechanisms. The knowledge gained will provide a solid foundation for the development of new strategies to prevent, delay, or reverse T1D.